Epigenomic analysis of cell-free nucleosomes for cancer research

PROJECT SUMMARY
Cell-free DNA (cfDNA) levels are elevated in the blood of individuals with cancer, leading to increased
interest in liquid biopsy (LB)-based assays for disease diagnostics and monitoring. Despite this, current cfDNA
assays are challenged by limited sensitivity and specificity to differentiate between cell types and disease states.
cfDNA is primarily found as cell-free nucleosomes (cfNucs), which consist of histone octamers wrapped in DNA.
Nuc features, such as the presence and genomic localization of histone post-translational modifications (PTMs),
play important roles in gene regulation and are highly associated with tissue type and disease state. As such,
the epigenomic analysis of cfNucs has the potential to deliver a transformative method of research that can
provide the specificity required to diagnose and differentiate between diseases that is lacking from current
assays.
To meet this need, EpiCypher is developing cfNuc-seq, the first commercial platform for the epigenomic
analysis of histone PTMs on cfNucs. Previous attempts to develop approaches for analysis of histone PTMs on
cfNucs exhibited low sensitivity and were not truly quantitative. The innovation of this proposal is the application
of ultra-affinity detection reagents to develop a novel, highly sensitive immunoprecipitation-based workflow to
quantitative compare cfNucs across disease states. Our approach will leverage EpiCypher’s novel recombinant
DNA-barcoded designer nucleosome spike-in controls to enable normalization and quantitative cross-sample
comparison, which is essential due to the low and variable abundance of cfNucs across patients and disease
states. The goal of this Phase I study is to perform foundational work towards developing and commercializing
the cfNuc-seq platform. Towards this goal, we will first develop optimized assays to profile distinct chromatin
compartments (Aim 1). We will then demonstrate the ability of our assay to detect distinct cancer cell signatures
in clinical samples (Aim 2), demonstrating strong proof-of-concept for our approach. In subsequent Phase II
studies, we will expand target validation and develop and launch high-throughput cfNuc-seq assays and services
to enable exciting new biomarker and diagnostics research.

Public health relevance
PROJECT NARRATIVE The analysis of cell-free DNA is a promising non-invasive method for disease diagnostics, yet existing assays are challenged to deliver the sensitivity and specificity required to differentiate between disease states. To meet this need, EpiCypher is developing a novel epigenomic assay for quantitative genomic mapping directly from liquid biopsy samples. This innovative platform will enable high-throughput epigenomic analysis, unlocking access to the wealth of information within liquid biopsy samples and opening the door to exciting advancements in biomarker and diagnostics research.